Skin Biology Resource-Based Center at UCI

The broad, long-term objective of the UC Irvine Skin Biology and Disease Resource-based Center is to promote significant and innovative discoveries in regulatory
mechanisms in skin biology and disease through cross-fertilization between multiple
disciplines, integrated through systems biology. The mission of the Administrative Core
is to centralize the leadership and operations of the Center, and to provide the
administrative support needed to meet the broad, long-term objective of the Center.
The Administrative Core will exert leadership for skin biology research at UCI and
nationwide and oversee outreach and enrichment activities of the Center that will
expand the community of scientists pursuing NIAMS-mission research. The Center is
led by Director Bogi Andersen and Associate Directors Anand Ganesan and Arthur
Lander, with input from the Executive and Advisory Committees. The Administrative
Core will manage funds and other Center activities; oversee communications; set
milestones and oversee surveys and other methods of evaluations; and oversee
Community Engagement efforts. The Administrative Core also runs a series of
programs of enrichment, including weekly Skin Club, monthly seminar series, and
yearly symposia, as well as several mechanisms for seed grant and other funding
types that advance the specific aims of the Center in the upcoming cycle. In the first
cycle, the Center Administration successfully enhanced collaborations and synergy
among research community members and attracted new researchers to the study of
skin biology and disease. The initial funding of the Center spurred a marked increase
in technology development, innovative research publications, and grant funding. By
servicing the various needs for the three resource Cores and the P30 research
community members, the dedicated effort and strong support of this centralized
Administrative Core provides added value and enhances the synergy of the research
community of the UC Irvine P30 Center.

Public health relevance
The Center promotes interdisciplinary research in basic skin biology and disease that will be relevant for understanding and treating skin diseases.